A Novel VpreB1 Anti-body Drug Conjugate for the Treatment of B-Lineage Acute Lymphoblastic Leukemia/Lymphoma

A Novel VpreB1 Antibody-Drug Conjugate for the Treatment of B-Lineage Acute Lymphoblastic
Leukemia/Lymphoma
B-cell acute lymphoblastic leukemia (B-ALL) is the most common malignancy in children and young adults. B-
ALL relapse is a common problem among infants, adolescents, and adults at all stages. B-ALLs that relapse
after cell-based therapies demonstrate antigen remodeling, down-regulation of targeted antigens, and lineage
switches to different types of leukemia. However, the molecular and cellular mechanisms that lead to the
emergence of resistant leukemic cells are not well understood.
Nearly all B-ALL cases share a restricted repertoire of B-cell surface markers. Cell-based therapies targeting
these surface receptors unfortunately eliminate all normal B cells, causing pan B-cell ablation and immune
dysregulation. This leads to serious complications and the risk of death due to infection in a significant fraction
of people who have suffered multiple relapses. To improve patient safety, our project addresses the problems
of relapse, opportunistic infections, and organ toxicities in B-ALL.
The pre-B-cell receptor (pre-BCR) autonomously signals to carry developing B-cells through the pro- and pre-B
stages of differentiation. B-ALL is usually arrested at the pro- and pre-B stages of differentiation, where these
cells are subject to pre-BCR-mediated autonomous signaling, survival, and clonal expansion. We hypothesize
that our novel VpreB1 ADC against the pre-BCR will de-couple the pathways that allows leukemia cells to
survive and become resistant to conventional chemotherapy. Therapies like the one we are developing have
lots of toxicities, including side effects that harm liver cells and the cells of the immune system that makes
antibodies against infectious diseases.
Better immunotherapies can lead to less organ damage, reduce opportunistic infections, and directly target the
resistance mechanisms that lead to residual disease in B-ALL. No current B-ALL immunotherapies target
autonomous survival signaling. This project is being expressly developed to benefit children, who have unique
physiologies and toxicity profiles. By using an AcBut-Calicheamicin linker and payload, we will gain insight into
safety data that have been collected by the Children’s Oncology Group for children receiving similar linker-toxin
payloads. Our approach is responsive to the FDA’s Best Pharmaceuticals Act of 2017, which calls for new
drugs for children and young adults who face life-threatening diseases, including B-ALL in relapse or with high-
risk disease at diagnosis.
In summary and in response to PAR-20-292, our proposal describes the development of a novel biologic
agent, with strategies to mitigate treatment-related toxicities for children and young adults who require
treatment for B-ALL.
In this proposal, we will:
 Continue the developmental trajectory of a novel ADC to address the problems of relapse, opportunistic
infections, and other toxicities in the treatment of B-ALL;
 Evaluate how well our novel ADC targets residual disease in treatment-resistant B-ALL;
 Assess the survival and adverse drug effects of our ADC, especially its effect on organ toxicities and
infectious complications;
 Evaluate how well our novel ADC spares adaptive immunity in B-ALL.

Public health relevance
NARRATIVE Relapse is a common problem in B-ALL. In response to PAR-20-292, we will decouple autonomous cell survival at a critical stage of B-cell developmental with an immunoconjugate against the pre-B-cell receptor. Limited in scope to B-ALL stages of developmental arrest, the immunoconjugate (alternatively, antibody-drug conjugate) will exploit normal internalization and transport mechanisms to effect cell killing, but without pan B-cell ablation or imbalanced T-cell activation. The problems we are trying to solve are relapse, opportunistic infections, and off-target toxicities in children and adults with B-ALL.